Characterizing the role of cancer-associated U2AF mutations in immune dysregulation

PROJECT SUMMARY
This project aims to define the role of cancer-associated U2AF mutations in immune dysregulation.
Splicing, the process by which intronic sequences are removed from mRNA precursors, is coordinated by
machinery called the spliceosome. Mutations in components of the spliceosome and associated proteins have
been linked to a wide range of pathologies, but are particularly prevalent in myeloid neoplasms, where they
have been identified as drivers of abnormal hematopoiesis and of cancer progression. Several of these
mutations occur in U2 Small Nuclear RNA Auxiliary Factor 1 and 2 (U2AF1 and U2AF2), which together play a
key role in intron recognition. U2AF1 is one of the most commonly mutated splicing factors in the context of
cancer, whereas mutations in U2AF2 are less common, but have been associated with more aggressive
disease. Hyperinflammation and susceptibility to infection are also hallmarks of blood cancers. Notably, the risk
of severe sepsis among those with hematological malignancies is 15 times higher than the general population.
Under the current paradigm, dysregulated inflammatory immune pathways are linked to pathogenesis of
hematological malignancies, but the mechanistic connection between mutations in splicing factors and
dysregulated immune responses is poorly understood. Based on my preliminary data, I hypothesize that
mutations in the U2AF heterodimer contribute to hyperinflammation through changes in splicing of immune
transcripts. My proposal will characterize how cancer-associated mutations in U2AF1 and 2 lead to
dysregulation of the innate immune response in ex vivo and in vivo models of sepsis. In Aim 1, I will identify
and compare the consequences of disease-relevant mutations in U2AF1 and U2AF2 on the macrophage
inflammatory response to lipopolysaccharide. In Aim 2, I will define how U2AF mutations impact inflammatory
outcomes to sepsis in a mouse model. Training in long-read RNA-seq, CLIP-seq, and a variety of other
molecular biology techniques will not only ensure the success of this proposal, but will also provide me with the
skills necessary to one day lead a research program focused on understanding how the dysregulation of RNA
processing contributes to human disease.

Public health relevance
PROJECT NARRATIVE Hematological malignancies are associated with hyperinflammation that increases mortality risk in the context of severe sepsis. This proposal aims to (a) elucidate how cancer-associated mutations in key components of the spliceosome, U2 Small Nuclear RNA Auxiliary Factor (U2AF1 and 2), alter inflammatory gene expression, and (b) connect these mutations to immune dysregulation in a mouse model of sepsis. Determining the role of U2AF mutations in regulating inflammation may lead to the identification of novel therapeutic targets for cancer patients.